The impact of HSP72 on mitochondrial function and muscle metabolism

PROJECT SUMMARY
Heat shock proteins (HSPs) are induced in response to metabolic stress, and induction of HSP72 specifically,
is critical for protection against genetic and diet-induced obesity and insulin resistance (IR) in male rodents.
We previously identified HSP72 as a chaperone of the E3 ubiquitin ligase, mitochondrial quality control protein
Parkin. HSP72-knockout (KO) impaired Parkin action promoting mitochondrial dysfunction, increased
adiposity, muscle lipid accumulation and IR in male mice. Herein we provide preliminary evidence that female
HSP72-KO mice are lean insulin sensitive and glucose tolerant compared to WT controls. Female KO mice
induced Esr1/ERα to preserve metabolic homeostasis by activating a Parkin-Drp1 axis in the control
mitochondrial form, function, and health. Herein, we propose two aims to test the impact of HSP72 expression
on mitochondrial form and function in the context of biological sex. SPECIFIC AIM 1. We will conduct studies
in conditional muscle-specific Hspa1a deletion mouse model (mHSP72KO) to determine how HSP72 regulates
the E3 ubiquitin ligase Parkin and fission regulatory partner Drp1 in the control of mitochondrial remodeling
and fatty acid metabolism. We will determine the phenotypic differences and molecular mechanisms underlying
the sexual dimorphism in metabolism in mHSP72KO mice by leveraging large scale differential omics analyses,
AAV introduction of modified targets in muscle, and advanced molecular biology approaches in genetically
engineered and primary cells in culture. SPECIFIC AIM 2. Because Esr1/ERα is induced in HSP72-KO females
and these mice show improved metabolic health, we will interrogate the impact of HSP72 on ERα protein
turnover/autoregulation, as well as binding partner association, post-translational modifications, Esr1 promoter
accessibility and transcription factor binding. Since men show a higher prevalence of T2DM compared with
age-matched premenopausal women, it is important to understand the mechanisms underlying sex
dimorphisms in metabolism and metabolic disease susceptibility. This research is critical for the advance of
precision therapeutics required to address sex-specific differences in disease pathobiology.

Public health relevance
PROJECT NARRATIVE Cellular stress signaling by protein chaperones including HSP72 is a fundamental process that controls organelle function and metabolic flux to meet changes in energy demand. Impaired stress resilience is a hallmark of aging and chronic disease. The goal of this proposal is to identify the molecular mechanisms that underlie the myocellular actions of HSP72 and determine the underpinnings that contribute to sexually dimorphic actions of this chaperone on mitochondrial metabolism, ERα expression, and muscle function in rodents.